Cross Regulation of TGFB/elf, B-catenin and Vitamin D Pathways in Gastrointestina

Project 2. Cross regulation of TGFp/elf, p-catenin and vitamin D pathways in gastrointestinal cancers. Human hepatocellular carcinoma and gastric cancer are characterized by alterations in the cadherin/catenin adhesion and signaling system. In some situations this is a result of activating mutations in P-catenin and in others, inactivation or mutation of the E-cadherin gene. The alterations in cell signaling and cell adhesion that accompany these genetic changes likely contribute to the oncogenic potential of these and other foregut cancers. Defects in TGFp/smad signaling are also common in cancers of the liver and intestinal tract. In addition to its "canonical" effects the TGFp/smad pathway can also interact with the p-catenin/TCF transcriptional machinery and co-operatively regulate transcription of a number of genes. The phenotype of the elf'~ and e/f'/smacW^'mice, in which altered TGF(3 signaling is accompanied by changes in E-cadherin and p-catenin links these two pathways for the first time in a human disease and provides important clues regarding a potential common basis for the development of human foregut cancers. In our first aim we will use transgenic animal models, cell lines and explants to investigate the role of p-catenin signaling in hepatocellular, gastric and pancreatic cancers and determine the molecular basis of its cross-regulation by TGFp/smad signaling. We will specifically ask if activation of wnt/catenin signaling and the wnt/catenin regulated gene FGFBP is required for the tumorigenic phenotype of the elf'~ and elf'/smadf'and e\f'~ /smad3+/~ mice. In aim 2 we will test the hypothesis that the vitamin D pathway provides a potential preventive and therapeutic option for the treatment of HCC and GC. Preliminary data demonstrates that the wnt/p-catenin/TCF pathway is a key intermediary in the cancer preventive action of vitamin D and its analogues. Vitamin D represses p-catenin signaling and p-catenin activates VDR. Both smads and p-catenin can bind directly to the vitamin D receptor (VDR) and potentiate its transactivation activity. Vitamin D and its analogues are potent repressers of the growth of several different tumor types including hepatocellular and gastric cancer and vitamin D is already in early clinical trials for the treatment of hepatocellular cancer. In aim 2 we will test the activity of vitamin D and of newly developed "p-catenin specific" vitamin D analogues in the animal models described above and use VDR knockdown in vitro and VDR"'" transgenic animals to examine to role of the vitamin D receptor. A therapeutic strategy involving ligand-mediated activation of the VDR offers the potential benefit of repressing p-catenin signaling and activating the TGFp pathway at the same time as VDR is activated. These data will be linked to the expression of activated p-catenin and markers of altered TGFp/smad signaling in 120 frozen hepatocellular carcinomas and paired control tissues. This collection, annotated with pathological, clinical and outcome data will provide an unprecedented opportunity to compare our transgenic animal data directly with human material.